Water Contaminants and Cardiovascular Risk: the Jackson Heart Study

PROJECT SUMMARY/ABSTRACT
In Jackson, MS, decades of under-investment in public water system infrastructure have resulted in severe
disruptions to water access and diminished water quality. Jackson has been under a consent decree since 2012
for failing to meet operational and maintenance standards and continues to have boil water notices issued
regularly, eliciting concern about the health effects of chronic water contaminant exposures. Despite emerging
recognition of the importance of environmental exposures in cardiometabolic-cardiovascular disease (CM-CVD)
risk, few epidemiologic studies have investigated the CM-CVD effects of public water contaminants, even though
these data can prioritize policy-based solutions to limit their impact. In this context, the flagship NHLBI/NIMHD-
funded Jackson Heart Study (JHS), a prospective cohort study of 5,306 African-American adults, offers a rare
opportunity to evaluate the effects of chronic water contaminant exposures on CM-CVD. In preparation for this
application, we extracted all 165,580 compliance monitoring records (2000-2023) collected by the Mississippi
Department of Health for 74 water systems serving Madison, Hinds, and Rankin counties comprising JHS
(encompassing 38 unique ZIP codes), demonstrating (1) substantial temporal variability (seasonal/yearly) in
prioritized water contaminants (e.g., total trihalomethanes, haloacetic acids, lead) across these water systems;
(2) select water contaminants linked to CM-CVD (e.g., lead, disinfection byproducts) are higher in water systems
serving JHS communities compared to those nationwide. Strikingly, disinfection byproducts and lead are largely
unrelated to source water and are directly related to the deterioration and management of water system
infrastructure, relevant to the ongoing Jackson water crisis. Our central hypothesis is that water toxicants
(captured by water system monitoring records and quantification of ≈1000 circulating chemicals in the blood
[“molecular exposome”] pioneered by our group) will be associated with CM-CVD phenotypes over ≈2 decades
in JHS. In Aim 1, we quantify 26 public water contaminant exposures (including disinfection byproducts,
inorganic metals, radionuclides, organic compounds) for all JHS participants over ≈2 decades and measure their
association with key CM-CVD risk factors (e.g., blood pressure, insulin resistance, obesity). Aim 2 provides a
complementary biochemical approach, quantifying relation of the molecular exposome–and its changes over
time–with these environmental exposures over ≈2 decades and measuring their relation to CM-CVD phenotypes.
In Aim 3, we examine association of both water monitoring records and biochemical exposures (molecular
exposome) with 20-year incident CVD risk, including how these relations may be mediated by the effect of water
contaminant exposures on traditional CM-CVD risk factors. If successful, this application will define the
importance of water toxicant exposures to CM-CVD over 2 decades in a highly vulnerable, minoritized community
with a contaminated water supply, with direct implications for policy. Resources generated here will be accessible
to the scientific community for future discovery and comparison to other populations.

Public health relevance
PROJECT NARRATIVE Neglect of the Jackson, MS, water system has led to widespread water contamination in recent decades and potential downstream health effects. Many toxicants present in a contaminated water supply can contribute to cardiovascular risk via high blood pressure, diabetes, and obesity. We use innovative methods to quantify water exposures over 20 years for participants in the Jackson Heart Study and test their association with key cardiovascular and metabolic outcomes to inform policy interventions to reduce the impact of the water crisis on cardiovascular health.